Administrative Core

ADMINISTRATIVE CORE
Project Summary/Abstract
The mission of the Mississippi INBRE (MS INBRE) is to enhance biomedical research capacity of Mississippi
through building a network of colleges and universities to promote competitiveness, provide access to
infrastructure to enable discovery, and establishing a pipeline of students into research and careers that impact
health. Through these activities MS INBRE will continue to positively address health disparities that plague
Mississippians. The role of the Administrative Core (AC) is to provide leadership and organizational support for
the network and coordinate the activities of all cores to ensure the program's three main goals are
accomplished: 1) Improve research capabilities at MS Primarily Undergraduate Institutions (PUIs); 2) Build
capabilities and collaboration among academics and community-based organizations; and 3) Develop a skilled
and diverse workforce in biomedical research and health-related. As the only statewide network that engages
all biomedical researchers in the state, it is critical that the AC efficiently coordinates network activities to
maximize impact. The MS INBRE cores have been designed to work synergistically to accomplish the overall
mission of promoting biomedical research excellence and workforce capacity of the state of MS. The AC
provides logistical support and oversight for all network cores. MS INBRE policies and procedures are
developed with active participation of the Steering Committee (SC) and the External Advisory Committee
(EAC). We have developed the following aims to efficiently carry out the goals of MS INBRE: 1) Provide
leadership and administrative support for all MS INBRE activities; 2) Establish and support research at PUIs
and community-based organizations (CBOs); 3) Enhance educational opportunities for students to enhance
the biomedical workforce; 4) Broaden participation of women and minorities in biomedical research and health-
related careers; 5) Promote sustainability and support of core facilities; 6) Represent MS regionally and
nationally; and 7) Coordinate formative and summative evaluations of all cores and the overall program.

Public health relevance
Project Narrative: The Mississippi INBRE Administrative Core coordinates all aspects of the MS INBRE. This will be accomplished by 1) providing leadership across activities, 2) facilitate the mission of the development research project program and CETC to support research projects 3) build a pipeline of students pursuing biomedical careers, 4) Broaden participation in underrepresented groups, 5) promote sustainability of research infrastructure, 6) Represent MS at the national level, and 3) evaluate the effectiveness of the network.